Fast-kinetics approaches to define direct gene-regulatory functions of MYB in leukemia

Project Summary/Abstract
Acute myeloid leukemia (AML) remains a therapeutic challenge and a significant public health burden,
necessitating development of novel therapies. The transcription factor (TF) MYB is a key transcriptional
regulator of stem and progenitor cells in the bone marrow and an AML proto-oncogene. In prior work Dr.
Pimkin has established MYB as a top selective AML transcriptional dependency and a critical regulator of AML
immune escape, making it an important target for further mechanistic and therapeutic exploration. This
proposal is focused on the mechanism and pharmacologic inhibition of MYB in AML, with an emphasis on pre-
steady state measurements of transcriptional dynamics and chromatin structure at ultra-fast kinetic resolution.
Aim 1 will characterize the functional relationship between MYB and CDK6:Cyclin D during the cell cycle,
testing the hypothesis that an interaction between MYB and the CDK6:Cyclin D complex links proliferation
control and differentiation arrest in AML. Experiments in Aim 1 will test whether the interaction between MYB
and CDK6:Cyclin D modulates the transcriptional output of MYB in different phases of the cell cycle and
whether this interaction is dependent of the CDK6 catalytic activity. Critical modalities in Aim 1 will include
targeted protein degradation, nascent transcriptomics, super-resolution microscopy and split-luminescence
measurements of protein-protein interactions in the cellular context. Results of Aim 1 will paint a
comprehensive mechanistic picture of the MYB function during the cell cycle and conceptually demonstrate
how an oncogenic TF couples lineage transcription with cell cycle control. Aim 2 will define the molecular
mechanism of action and test therapeutic efficacy of a novel small-molecule MYB modulator KI-TM1-001,
testing the hypothesis that KI-TM1-001 is a mixed MYB agonist/antagonist reflecting functional heterogeneity
of MYB-driven transcription. Experiments in Aim 2 will elucidate whether KI-TM1-001 inhibits a subset of MYB-
regulated genes by disrupting the interaction between MYB and TFIID, while displaying a distinct mechanism
of action at another subset of MYB-regulated genes where it acts as an agonist. Critical modalities in Aim 2 will
include methods of advanced proteomics aimed at an unbiased target engagement profiling of KI-TM1-001 to
identify its direct interactors, including photoaffinity/”click” assays and proteome integral stability alteration
assay coupled with high-resolution mass spectrometry (PISA). The efficacy of KI-TM1-001 as an AML
therapeutic will be tested in pre-clinical AML models. These experiments will create a well-validated chemical
probe for MYB function and a lead molecule for further therapeutic development. The environment for the
proposal includes combined expertise and resources of HHMI, Boston Children’s Hospital, Dana-Farber
Cancer Institute, Broad Institute and Koch Center for Integrative Cancer Research at MIT. The proposal is
designed to provide Dr. Pimkin with intensive training in cell cycle control and chemical biology, including small
molecule development and target engagement profiling, fostering his transition to independence.

Public health relevance
Project Narrative Acute myeloid leukemia (AML) represents an unmet need in pediatric and adult oncology due to its high incidence and poor treatment outcomes. The transcription factor MYB is a key AML proto-oncogene, a top enriched AML dependency and a critical regulator of AML immune escape after allogeneic bone marrow transplantation, making it a high-priority target for therapeutic development. This proposal seeks to 1) mechanistically characterize the oncogenic functions of MYB during cell cycle and 2) to develop a tool MYB inhibitor for use as a molecular probe and a lead molecule for therapeutic development. Results of this work will provide a mechanistic basis for further development of MYB-directed AML therapeutics.